Next Generation of HPV and Cervical Cancer Research in HIV+ Women

HIV(+) women have high risk of cervical precancer and cancer as well as infection with human papillomavirus
(HPV), the viral cause of cervical precancer/cancer. Recent advances in genetic/epigenetic methods provide
previously unachievable opportunities to study the HPV viral factors and other local infectious influences on the
natural history of HPV and development of cervical disease in HIV(+) women. Under this proposal, we will use
next generation (next-gen) sequencing to conduct precision HPV genomic analysis able to determine
whether a given HPV type detected at two or more time points is the same exact viral infection versus different
HPVs of the same type. These data will be used to comprehensively study: type-specific differences in HPV
persistence and their relation with precancer; the occurrence of HPV reactivation and how often reactivated
HPV persists and leads to precancer; the impact of immune status on each of these steps in HPV natural
history. If cervical HPV can reactivate and progress to precancer, it would preclude screening cessation at age
65 years (which is done in the general population). Furthermore, HPV DNA methylation will be studied, as we
found methylation in the HPV L1/L2 region very strongly associated with precancer/cancer, and pilot data
suggest similar associations between methylation and precancer may exist for HIV(+) women. This research
therefore will provide insight into the epigenetic modifications related to the development of cervical disease,
and could possibly be used to improve the specificity and positive predictive value of HPV testing. Importantly,
the cervicovaginal microbiome may influence both the HPV natural history and HPV DNA methylation and
will also be studied. A pilot study by our group showed reduced HPV prevalence with high relative abundance
of Lactobacillus crispatus but not other Lacobacillus species, and transition to a L. crispatus community state
type was associated with reduced incident HPV. The L. crispatus results were especially promising since the
protective effects were observed even with low CD4. However, the microbiota and HPV relationship needs to
be studied in appropriately designed HIV(+) cohort studies of adequate size before any future probiotic
intervention studies may be considered. There are currently little data regarding the impact of the microbiota on
HPV natural history/progression (building on Aim 1). We will also study the microbiota and HPV methylation
(building on Aim 2), as local microbiota was shown to alter methylation in neighboring tissue. Overall, these
integrated studies address critical aspects of HPV natural history/progression, with significant implications to
cancer prevention. This study will utilize semiannually collected specimens from the WIHS, the largest, long
term cohort of HIV(+) (N=2793) and high risk HIV(-) (N=975) women. The Specific Aims are, in HIV(+)
women, to study: (i) The role of reactivation in HPV natural history and precancer risk, using next-gen
“precision” HPV genomic assays; (ii) HPV DNA methylation and its relation with precancer risk; The
microbiome's impact on HPV natural history, HPV methylation, and HPV progression.

Public health relevance
Project Narrative HIV(+) women have high risk of cervical precancer and cancer as well as infection with human papillomavirus (HPV), the viral cause of cervical precancer/cancer. Advances in genetic/epigenetic methods provide previously unachievable opportunities to study HPV viral risk factors and other local infectious influences on HPV natural history and precancer risk in HIV(+) women. Specifically, under this application we will use recently developed next generation (next-gen) sequencing assays to study, in HIV(+) women: the role of HPV reactivation in cervical disease, the effects of HPV DNA methylation on precancer risk, and the impact of the cervicovaginal microbiome on both HPV methylation as well as cervical precancer.